Evaluation of an ongoing scale-up of a task shared, evidence-based package for integrating care for common mental disorders into primary health care in two under-resourced provinces in South Africa.

Many Southern African countries are confronted with the challenge of having to adapt their
health systems to respond to a changing disease profile characterized by a rise in multiple
chronic comorbidities. HIV, which is now considered a chronic condition, and tuberculosis
are increasingly co-occurring with a rising burden of non-communicable diseases (NCDs).
Included in this mix are Common Mental Disorders (CMDs), which interfere with adherence
and self-care, compromising global investments in vaccines, medications and other
treatments. The proposed scale-up study responds to the urgent need to generate
knowledge of how best to scale up integrated evidence-based practices for CMDs into real-
world primary health care (PHC) platforms for multiple chronic diseases in resource-
constrained settings. Our proposed study will be layered onto the ongoing scale-up of our
task-shared, evidence-based package for integrating care for CMDs into this integrated
chronic care system in PHC facilities with the following specific aims: Aim 1: Utilize the RE-
AIM framework to examine the reach, effectiveness, adoption, implementation and
maintenance of scale-up in the two different real-world district contexts. Aim 1.1: Track RE-
AIM outcomes in implementing facilities; Aim 1.2: Engage in continuous quality improvement
at facility and district levels. We will examine indicators of mental health screening, referral,
treatment uptake, adherence, quality of care; health care worker training, knowledge,
attitudes and satisfaction; patient outcomes and satisfaction; cost impact; and organizational
integration. Aim 2: Utilize the Consolidated Framework for Implementation Research (CFIR)
framework to examine and adapt to multi-level factors that influence implementation in the
two different real-world district contexts. Aim 2.1: Identify and assess multi-level factors
affecting package implementation; Aim 2.2: Engage health system managers and planners
at district, provincial and national levels in a participatory process to propose adaptations for
continued efficient implementation. We will conduct key informant interviews in high-,
medium- and low-performing clinics to identify multi-level factors and engage stakeholders in
a participatory process.